Consolidated Basic Cancer Research Program

PROJECT SUMMARY – OVERALL
The vision of the Wistar Cancer Center is to conquer cancer through outstanding research, education and
partnership, and its mission is to merge basic, translational, and patient-oriented cancer research in a
single scientific continuum. Rated Exceptional (Impact score, 19) at the 2013 renewal of the Cancer Center
Support Grant (CCSG), the Cancer Center has continued on a path of scientific excellence, impactful
contributions in basic and translational cancer research, and productive partnerships with neighboring
academic Institutions. Leveraging the 2014 opening of the Fox Research Tower, the largest building built on
Wistar campus, a science-focused leadership where the Cancer Center Director (Dr. Altieri) is also Institute
President and Chief Executive Officer (CEO) and a nimble, opportunity-driven administration, the Cancer
Center has recruited 10 new members during the last CCSG budget cycle, expanded technological capabilities
in all Shared Resources, and realigned Programs for optimal scientific impact and collaboration. Its basic
research contributions have elucidated fundamental underpinnings of tumorigenesis in chromatin organization,
non-coding RNA, local immunosuppression and metastatic competence, whereas disease site-specific themes
in melanoma and ovarian cancer have run the gamut from defining new oncogenic pathways to unraveling
mechanisms of drug resistance to bringing novel therapeutics to the clinic. Against this backdrop, the Cancer
Center currently receives $12.4 million in peer-reviewed, cancer-related funding, with $8.9 million from the NCI
for an exceptional cancer focus of 76%. The three Programs in the Cancer Center have succeeded in a
uniquely collaborative approach to cancer research: 76% of all peer-reviewed funding and over 40% of
“discovery” publications in the Programs are currently the product of multi-investigator collaborations. For a
Cancer Center with only 27 members, Wistar now contributes to three Specialized Programs of Research
Excellence (SPOREs), five Program Project grants, six multi-PI awards, and four U-type grants. The
overarching goal of the Cancer Center to move its basic discoveries to the clinic has been met with a landmark
agreement with the Helen F. Graham Cancer Center (HFGCC), the first partnership in the nation to bring
together two NCI-sponsored programs: an NCI-designated “basic” Cancer Center (Wistar) and a member of
the NCI Community Oncology Research Program (HFGCC). This has enabled impactful collaborations
between Wistar scientists and HFGCC clinicians, bringing cutting-edge cancer research to the community. The
Cancer Center will continue on this successful trajectory of accomplishments during the next CCSG budget
cycle, creating new, multidisciplinary research themes in basic and translational tumor immunology, early-
stage academic drug discovery, and exploitation of tumor metabolism for novel cancer therapeutics. As an
organization solely dedicated to biomedical discovery, Wistar is uniquely poised to continue making
transformative advances in basic, translational, and patient-focused cancer research.

Public health relevance
PROJECT NARRATIVE – OVERALL Members of the Wistar Cancer Center elucidate the mechanistic underpinning of malignancy, pursue innovative disease models, and identify novel tumor vulnerabilities suitable for therapeutic intervention. Driven by collaboration and partnership, the Wistar Cancer Center delivers on innovative basic and translational cancer research, brings cutting-edge science to the community, trains the next generation of research leaders, and strives to advance its discoveries to the clinic for the benefit of cancer patients and their families.